ENDOCYTOSIS OF BLOOD PROTEINS IN INSECT DEVELOPMENT

A study of the role of blood proteins and receptor-mediated endocytosis in the metamorphosis and egg formation of insects is proposed. Vitellogenin, lipophorin, and three hexameric storage proteins, which comprise most of the blood proteins of Hyalophora pupae, are to be isolated and labelled for use as physiological probes. A series of tests is designed to assess whether the probes are handled by the tissues of the insect in the same manner as before isolation and labelling. The fates of the probes when presented to developing tissues either in situ or on isolation in a culture system will be examined. It is anticipated that each protein will prove to be endocytosed by a particular tissue and at particular stages of development, and that it will either be incorporated into cellular structures intact, as in the case of vitellogenin, or hydrolyzed to release amino acids for use in synthesizing other tissue proteins. The binding selectivity of each target cell for the five probes will be determined, and since the first two to be isolated have proven to be mannose-rich glycoproteins, the role of sugars in ligand binding and endocytosis will be studied.